Hispanic Alliance for Clinical and Translational Research (Alliance)

Improving health care for the medically underserved, including our Hispanic population, afflicted by
prevalent diseases, such as cancer, cardio-metabolic and infectious diseases, remains a major challenge.
The current application is to support the development of Hispanic Alliance for Clinical & Translational Research
in Puerto Rico (Alliance), which aims to build on the existing infrastructure of the Puerto Rico Clinical and
Translational Research Consortia (PR-CTRC an RCMI-CTR) and the unique expertise on emerging infectious
diseases and the study of disaster-related conditions and their impact on Health. The objective of the Alliance
is to serve as the catalytic center to enhance the competitiveness of investigators to conduct research and
obtain additional funding for clinical and translational research addressing highly prevalent diseases and
those that affect the medically underserved in Puerto Rico. The long-term goal of the Alliance is to
transform clinical and translational research in Hispanic populations in the Mainland and in Puerto Rico by
promoting inter-disciplinary collaboration and leverage of resources to address diseases affecting
Hispanic communities.
Successful implementation of the Alliance will advance our fundamental knowledge of Hispanic health
in this ethnic subgroup, which is increasingly represented in the U.S. mainland population. The Alliance is
innovative because it will: (1) create a Hispanic-centered research hub integrating resources to support
researchers in PR and national partners; (2) implement the Hispanic Real World clinical research data
warehouse; and (3) establish a Community Health & Research Council comprised of diverse community
partners emphasizing a community-centered, bi-directional research focus to impact health policy and
ultimately improving health outcomes in our Hispanic community. The Alliance overall aims are specified
below.
Specific Aim 1: Enhance an island-wide infrastructure and human resource network and synergize with local
and national partners to conduct clinical and translational research in Puerto Rico.
Specific Aim 2: Provide professional development activities to enhance the ability of investigators to develop
competitive clinical and translational research programs with emphasis on Hispanic health needs.
Specific Aim 3: Facilitate the generation and dissemination of knowledge to and from the bench and the
community to improve health outcomes that affect Hispanic communities in Puerto Rico and across United
States.
Specific Aim 4: Catalyze and sustain the integration of trans/multi/inter disciplinary collaborations to conduct
clinical and translational research within and across institutions, organizations, community networks and health
programs in Puerto Rico and other IDeA states.

Public health relevance
Project Narrative The proposed Hispanic Alliance for Clinical and Translational Research is relevant to public health because it will help advance our fundamental knowledge of ethnic- specific factors that could explain the disproportionate burden of certain diseases, and the limited or lack of effective treatment for this ethnic subgroup, which is increasingly represented in the US mainland population. The long- term goal of the Alliance is to transform clinical and translational research in Hispanic populations in the Mainland and in Puerto Rico by promoting inter- disciplinary collaboration and leverage of resources to address diseases affecting Hispanic communities. The project is relevant to the NIH mission because it will contribute with training the next generation of scientists, develop research capacities, and will enhance the diversity of the scientific workforce.